Impacts of parental benzo[a]pyrene exposure on offspring’s bone development

Biomedical research workforce diversity is critical for developing solutions for complex human health
challenges. To address this issue, the recruitment, support, and mentorship of the M.S. thesis of a first-
generation, Hispanic biomedical science student is one of the objectives of this research supplement to
promote diversity in health-related research (following PA-21-071) in the framework of research
conducted within the project “Impacts of parental benzo[a]pyrene exposure on offspring’s bone
development” (1R15ES032936-01). The parent project aims to decipher the role of epigenetic
mechanisms, DNA methylation, and microRNAs, in the development of parental benzo[a]pyrene (BaP)
exposure-induced bone impairment. The present proposal will extend and complement this research by
addressing histone modifications in larval and adult bone cells in a temporal and spatial manner. Using
immunohistochemistry, the candidate will assess alterations for multiple histone acetylation and
methylation markers resolving how parental BaP exposure is modulating the histone profile in the
osteoblast cell lineage in the offspring. As a result, the student will obtain experience in an emerging area
of biomedical sciences and toxicology research, shedding light on potential mechanisms through which
ancestral BaP exposure elicits its effect on offspring bone health. This research will result in the
identification of possible developmental markers for later life-stage osteoporosis risk. Moreover, a very
passionate junior scientist from an underrepresented community will be equipped with state-of-the-art
tools to pursue a career in biomedical sciences. Discriminating epigenetic marks and genes associated
with cross-generational toxicology, the proposed research provides a platform for the development of
prognostic/diagnostic tools to identify the risks of adverse effects of parental chemical exposure.

Public health relevance
Improving the inclusion of individuals with minority background in biomedical sciences, this supplement grant application seeks support for the professional development of a first-generation Hispanic student. The student will conduct high-impact research projects to define the epigenetic mechanisms associated with long-term bone impairment upon parental Benzo[a]pyrene exposure. This research plan extends from the parent R15 award addressing histone modifications in larval and adult bone of the Japanese medaka bone model and provide a sound mentorship plan for a successful career in environmental health.